CORE--TECHNICAL

The objective of the technology core is to provide continued institutional support for maintaining and upgrading PACS infrastructure and providing these resources to the program project grant for the purpose of research. This core will specifically: [1] maintain a PACS network and storage, maintain and updating viewing stations as required; [2] integrate all new acquisition equipment (CT, CRs, MR) into existing PACS infrastructure; and [3] provide quality control and quality assurance for technologies developed in this Program Project Grant for implementation of clinical environment.